Administrative Core

SUMMARY: ADMINISTRATIVE CORE
The Strategic Vision for the Gulf Coast Center for Precision Environmental Health (GC-CPEH) is to
catalyze translational EHS research within research-intensive institutions of the Texas Medical Center
(TMC) to advance our understanding of individual- and place-based environmental determinants of
human health and disease. The Administrative Core is led by BCM Director Dr. Cheryl Walker and Deputy
Director Dr. Elaine Symanski, and Co-Director for UT Dr. Cornelis Elferink, supported by an experienced Center
Administrator, Dr. Heyreoun An Han Directors are guided by an Executive Committee that includes Facility Core
and Program Directors, and an inclusive Internal Advisory Committee (IAC) made up of all Center leaders and
Career Development Program mentees participating in the Leadership Development Program (LDP) and
the CEC Community Advisory Board (CAB). The Core promotes advancement and translation of EHS
research by supporting 1) Thematic Focus Area activities; 2) Organization of symposia, seminars/workshops
and the Center annual retreat; 3) Pilot Project Program (PPP) activities and tracking outcome metrics; and 4)
Administering the Matching Funds Core Utilization Program which promotes access to Cores to accelerate
member research and career advancement. The Core also ensures effective communication within GC-CPEH
and to external audiences, to establish the Center as a recognizable entity in human environmental health
research and translation, and coordinates and assists the CEC in organization and programming for outreach
activities and CAB meetings. The Administrative Core oversees the Plan for Enhancing Diverse Perspectives
(PEDP) and Data Management Plan for the Center. This Core also supports the Plan for Enhancing Diverse
Perspectives (PEDP) and Data Management Plan for the Center, and Community Engagement Core activities
to communicate with community members, policy makers and the CAB. The Specific Aims of the Administrative
Core are: Specific Aim 1: Develop and maintain an administrative structure that effectively manages the EHS-
CC, advances the careers of junior investigators, and promotes the GC-CPEH Strategic Vision; Specific Aim 2:
Catalyze impactful EHS research, facilitate CEC impact on its community and policy-maker audiences, and
advance research translation to improve human environmental health; and Specific Aim 3: Provide the
infrastructure to track, maintain, and disseminate GC-CPEH activities and outcome metrics to both internal and
external audiences.